Elucidating Regulation of Cell Fate Specification in Human Cortical Development to Understand Etiology of Neurodevelopment Disorders

PROJECT SUMMARY
The human brain has an expanded cortex compared to its closest relatives, and this outer layer of the brain
provides humans with complex functions including integration of sensory inputs, judgement, and conscious
decision making. Each of these areas of the cortex contains unique cell types, density of cells across layers,
transcriptional identities, and connectivity patterns that emerge during developmental timepoints. Importantly,
virtually all neurodevelopmental and neuropsychiatric disorders develop with cortical area specific phenotypes,
and often with specific laminar manifestations as well. The vulnerabilities to these disorders are established
during these developmental timepoints. While the existence of early morphogenetic gradients is known to
establish the poles of the cortical areas, and “inside-out” neurogenesis lays the foundations for the six layers of
the cortical plate, open questions regarding the transcriptional regulators of these terminal fates remains partially
unknown in the developing human brain. Recent efforts through the BRAIN Initiative and others have generated
expansive single-cell characterizations of the developing human cortex, providing an opportunity to mine these
datasets in order to identify novel regulators of these cell fate specification events. Additionally, previous work
characterizing the developing human brain has generated an “atlas of arealization” that identifies the genes that
are expressed in each cortical area across developmental time. This dataset serves as a hypothesis generating
tool for the identification of specific mechanisms of cortical arealization. Cortical organoids are three-dimensional
models of the developing human brain that enable genetic access to and mechanistic interrogation of the
developing human brain. These models have revolutionized our ability to model and characterize human
development and neurodevelopmental disease, but recent characterizations of the system have identified that
these organoids are not cortical area specific, but can be used for the exploration of terminal specification factors.
Understanding the detailed mechanisms of cortical arealization and laminar specification could enable not only
more specific understanding of disease etiology, but could also improve organoid models for the study of normal
development and disease. Thus, this proposal will evaluate the signals that drive cortical arealization and laminar
identity using both a bioinformatic and CRISPR activation screen. Additional efforts will explore the timing and
permanence of these specification factors via knockdown of candidate regulators; proof of the pipeline will be
executed with the factors identified in our preliminary studies related to the specification of FEZF2 deep layer
neurons. Together, these studies will establish mechanisms and models of arealization and laminar identity in
the developing human brain.

Public health relevance
PROJECT NARRATIVE The human brain is comprised of diverse, functionally relevant areas that enable complex cognition, perception, and judgment; importantly, neurodevelopmental disorders present with distinct phenotypes across cortical areas and layers. However, how these terminal cell fates emerge is still not well understood and because of this gap in our knowledge, stem cell based models of the developing human brain such as cortical organoids do not reflect the unique aspects of individual cortical areas. This proposal will survey the role of prefrontal cortex enriched transcription factors and terminal factors for laminar fate specification to evaluate the relative contributions of these signals in driving cortical arealization in order to improve understanding of how areas and layers develop and to better understand how neurodevelopmental disorders emerge.